NIDA DATA, STATISTICS, AND CLINICAL TRIAL SUPPORT CENTER MANAGEMENT AND SUPPORT. 09/05/2022 - 09/04/2023. N01DA-22-2253. TASK ORDER 75N95022F00001 (TO

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.